Biochemistry Core

PROJECT SUMMARY
The Biochemistry Core supports projects associated with the Center for Pediatric Research by providing
consultation and technical support for protein-protein interaction screening, multi-analyte detection, and lipid
profiling. The Core will continue to perform BioID as a cutting-edge approach to screen for protein-protein
interactions. Furthermore, the Core will expand its technical abilities and provide services for multi-analyte
detection and quantification of proteins as well as gas chromatography-mass spectrometry (GC/MS) for detection
and quantification of fatty acids and sterols. The Core will also provide assistance in the preparation of
manuscripts and funding applications as they relate to the services provided. By providing these services in-
house, the core will directly interface with the investigators during experimental design, protocol establishment,
troubleshooting and execution as well as organize any further analysis outside of the core. The purpose of the
Biochemistry Core is to support the goals of its users, namely independent scientists studying how biochemical
processes on stem/progenitor cell plasticity influence the basis of human health and disease.